Emory Alzheimer's Disease Research Center

SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core of the Goizueta ADRC at Emory University provides the infrastructure to support and
facilitate the growth of clinical and research activities for Alzheimer’s disease and related disorders (AD),
capitalizing on the considerable strengths of the neuroscience community at Emory. The Administrative Core
will provide the leadership, overseen by the Director, Associate Directors and Administrator, to ensure that the
resources available to the ADRC are utilized judiciously and effectively to provide the greatest impact in
shepherding the Center’s goals of discovery and translation of new targets and mechanisms to enable early
identification, early interventions, and ultimately prevention of AD. The Administrative Core will address the
following Aims: 1) Foster active communication, coordination, integration, and planning of all ADRC activities,
including Cores and the Research Education Component (REC), and ensure optimal utilization, leveraging,
and management of resources, 2) Promote and encourage innovative research to advance our understanding
and treatment of AD and ADRDs through the solicitation, review, award and support of Developmental
Projects, philanthropically-supported pilot projects, and junior investigators, 3) Enhance AD and ADRD
research, clinical care, and education by maximizing opportunities for interaction with other ADRCs and
AD/ADRD investigators, and with local, regional, national, and international institutions and agencies, and 4)
Cultivate an environment that promotes the highest standards of ethics in clinical care and research, including
compliance with human subjects, animal welfare, fiscal policies, and scientific integrity. The ADRC will achieve
these Aims by bringing together the many talented multidisciplinary researchers from the many departments
and centers at Emory and other local institutions, continue to foster collaborations with the larger AD research
community, engage the community to educate about the importance of research and research participation
and foster the training of future ADRC investigators and leaders.

Public health relevance
Per RFA-AG-20-004 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.